The intersection of AI, clinical practice and health outcomes with linked Medical-Dental electronic records.

Abstract
Oral health disparities in the United States are a significant public health issue, particularly among underserved
populations, including Hispanics, non-Hispanic Blacks (NHB), and rural non-Hispanic Whites (NHW). Poor oral
health not only leads to oral diseases but is also closely linked to systemic conditions such as diabetes,
cardiovascular disease, and oral cancer (OC). Hispanics and NHBs are twice as likely to be diagnosed with late-
stage OC, resulting in survival rates below 40%, compared to over 80% for non-Hispanic Whites. This highlights
the urgent need for integrated healthcare that connects oral and general health to improve outcomes for these
vulnerable groups. Despite efforts to integrate medical and dental care, oral healthcare remains largely
disconnected from the broader healthcare system. The proposed study aims to connect oral health with
systematic health to better integrate medical and dental care by developing linked databases, creating real-time
clinical tools to improve oral clinical care, and identifying individuals at elevated risk for OC using fair and
responsible artificial intelligence (AI) methods. We will leverage existing electronic health records (EHR) and
electronic dental records (EDR) from three major dental institutes [Temple University School of Dentistry (TU),
University of Colorado School of Dentistry (UC), and West Virginia University School of Dentistry (WVU)] that
serve underserved populations to develop and implement clinical tools that may facilitate dental practice and
reduce oral health disparities related to OC. The four aims are: (1) develop real-world AI-ready datasets to
understand and reduce oral health disparities; (2) create a clinical tool that provides real-time medical history,
lab values, and medication information to dental providers; (3) predict OC risk using federated learning across
multiple institutions with responsible and interpretable AI methods; and (4) explore the feasibility of implementing
the clinical tool and AI prediction model at Temple University. This multi-site initiative addresses a critical gap in
healthcare delivery for underserved populations by integrating medical & dental care. It has the potential to
reduce oral health disparities by ensuring early OC diagnosis and access to up-to-date patient information from
dental providers. The clinical tools and OC prediction risk tailored to diverse populations have the potential to
detect early OC diagnosis and treatment, leading to improved OC prognosis and OC outcomes aligning with
NIDCR's strategic priorities and setting a new standard for reducing health disparities and advancing precision
dental care.

Public health relevance
Project Narrative By integrating medical and dental care, this multi-site initiative aims to address a critical gap in healthcare delivery and oral cancer (OC) related oral health disparities for underserved populations (Hispanics, non-Hispanic Blacks, and rural non-Hispanic Whites) who are at higher risk for OC by providing early diagnosis and improving information flow. This study will use state-of-the-art informatics, AI, and AI de-biasing and fairness methods to develop two tools: 1) a clinical tool that will demonstrate patients' most up-to-date medical information for dental providers to improve clinical care and 2) an OC prediction model tool for early OC diagnosis for improved prognosis. The clinical tool and OC prediction risk tailored to diverse populations have the potential to detect early OC diagnosis and treatment, leading to improved OC prognosis and OC outcomes.